MCEMP1 is an adaptor for KIT receptor for mast cell proliferation

Project Summary/Abstract:
Mast Cell Expressed Membrane Protein 1 (MCEMP1) is a transmembrane protein highly expressed in
lung-resident mast cells. Interestingly, MCEMP1 is one of the top inducible genes in several inflammatory lung
diseases including asthma. Indeed, asthma patients at exacerbation stage show higher expression of MCEMP1
than asthma patients at recovery stage. However, a cellular function of MCEMP1 in mast cells and a pathological
role of MCEMP1 in asthma are entirely unknown. In preliminary study, I discovered that MCEMP1 interacted
with KIT receptor on the surface of mast cells. While an immunoglobulin E (IgE)–FcεRI complex activates mast
cells to induce degranulation, KIT surface receptor and its ligand stem cell factor (SCF) are critical for the
proliferation of mast cells. Upon SCF stimulation, peritoneal mast cells from Mcemp1–/– mice showed decreased
proliferation compared to those from wild-type mice. In addition, SCF-mediated in vivo expansion of lung mast
cells was significantly reduced in Mcemp1–/– mice. Importantly, Mcemp1–/– mice showed reduced lung
inflammation in asthma model. Based on these, I hypothesize that MCEMP1 is a critical adaptor for KIT
receptor signaling that promotes SCF-mediated mast cell proliferation and contributes to asthma
exacerbation. Herein, I seek to address the following: (i) a cellular role of MCEMP1 in SCF-induced mast cell
expansion by potentiating KIT receptor signaling. (ii) a pathological role of MCEMP1-mediated mast cell
expansion in the progression of severe asthma. (iii) Lastly, I will develop therapeutic approach to inhibit the
pathologic function of MCEMP1 in asthma. Collectively, this study will not only define the pathobiological role of
MCEMP1 in mast cell expansion and asthma progression, but also provide novel insight into a new therapeutic
target for asthma. This award will support a new molecular mechanism of mast cell proliferation and an important
mechanistic finding in the field of asthma.

Public health relevance
Project Narrative Mast Cell Expressed Membrane Protein 1 (MCEMP1) is one of the top inducible genes in the lung of asthma patients, yet a pathological role of MCEMP1 is entirely unknown. I will address a role of MCEMP1 in KIT-mediated mast cell proliferation and asthma development, ultimately identifying a new therapeutic strategy for treating asthma.